Academic Consortium of Criminal Justice Health

Incarceration impacts a large proportion of people living in the United States. People who are
incarcerated are more likely to experience disease and early mortality. Investment in improving
systems of healthcare in criminal-justice settings are necessary to improve public health. The
goal of this R13 application is to support scholarships and speakers at the annual Academic
Consortium of Criminal Justice Health (ACCJH) conference. The ACCJH conference was first
held in 2007 and brought together clinicians and researchers to improve healthcare in jails and
prisons. Since that time, there has been increase in the number of people who attend the
conference and deliberate outreach to people from outside of academia, including people with
firsthand experience of incarceration. The ACCJH conference is one of the only national
conferences that brings people from across the United States and globally to convene and
discuss pressing issues in carceral health. This 2-day conference will focus on emerging topics
at the intersection of incarceration and health. Scholarships provided by this grant will ensure
that early investigators and people with firsthand experience of incarceration can attend.
Speaker fees will allow for experts in the field to spend time sharing knowledge. The result of
the ACCJH conference will continue to be networking opportunities, fertile ground for research
development, and the opportunity to disseminate impactful research.

Public health relevance
The criminal-legal system impacts many people in the United States. People with firsthand experience of incarceration have with higher rates of disease and death. Multi-disciplinary collaborations across academic, government and industry informed by the voices of people who are incarcerated are necessary to improve access to healthcare in criminal justice settings. The Academic Consortium of Criminal Justice Health (ACCJH) is a conference that has brought together people to discussing pressing health topics in carceral health and build partnerships to develop solutions. This proposal for the R13 mechanisms requests funding from several NIH agencies to support the ACCJH conference through funding scholarships and speaker fees. The ACCJH conference will build systems of impactful research, emphasize opportunities for early career and provide opportunity to disseminate research towards the goal of improving healthcare in in criminal justice settings.